Exposomics and Alzheimer's disease Across the Life Course

Project Summary
Mount Sinai’s Institute for Exposomic Research requests support for an annually held international
series of 5 symposia focused on Exposomics, Aging, and Alzheimer’s disease Across the Life Course. The
exposome is the study of all the health relevant environmental factors encountered across life.
Exposomics is a complex “big data” science with branches that include climate and health, untargeted
chemical assays, satellite remote sensing, wearable devices, and social media mining among other
measures. Mount Sinai has been hosting Exposome symposia annually since 2018 and our team has
successfully hosted meetings internationally in Europe and Latin America already. Our goals are to
advance exposomic science globally in order to accelerate research in exposomics in Alzheimer’s Disease
and Related Dementias (ADRD). These symposia will foster new research collaborations and catalyze a
critical mass of researchers working in Aging and Exposomics. Many of the attendees, including junior
faculty, are or will become future leaders in the exposomics of aging. These conferences will also
targeted health disparities around ADRD and promote policy and research initiative designed to address
those disparities. Our R13 proposal has multiple highly committed partners already. Our meetings will
be held in 5 locations-Japan, Mexico, France, Rwanda and Meharry Medical College, a historically Black
College/University. We have strategically designed our program to promote diversity, equity and
inclusion in ADRD Exposomic Research and to address the role of environment and aging globally. By
doing so, we maximize its impact. Each symposia is preceded by a ½ day workshop (e.g. ArcGIS and
mapping the exposome, untargeted chemical assay and their analysis, mining google maps and mining
social media platforms are all examples of planned workshops). We will invite prominent speakers from
major research institutions. For example several NIH Institute directors as well as the NIH ECHO and All-
of-US program directors have been presenters at our symposia). Local experts from the host countries
will be prioritized as presenters, and we will include U.S. leaders in exposomic science and leaders in
ADRD research from across the country. Our poster sessions will bring together junior scientists with
established researchers, and we will use R13 funding for travel awards targeting underrepresented
scientists, junior faculty and trainees from developing/middle income countries and the U.S. Each
program is evaluated by attendees, and evaluation data will be used to improve each subsequent
symposium. We will track our ability to attract diverse participants. We will also track attendees and
activities employ a Kirkpatrick Model-based survey to measure participant satisfaction, increases in
knowledge, and utilization of exposomics in their research.
1

Public health relevance
Project Narrative Mount Sinai’s Institute for Exposomic Research proposes a series of 5 annual symposia on Exposomics, Aging and Alzheimer’s disease and Related Dementias(ADRD). Meetings will be held internationally with co-host institutions (see letters of collaboration) in Japan, Mexico, France, Rwanda and in the U.S. at Meharry Medical College. The symposia are designed to promote diverse research in exposomics in ADRD globally.